Host Response to Trauma Research Training Program

Abstract
Trauma is the most common cause of death in people under the age of 45 in the United States and
costs more than $400 billion annually for medical care and lost productivity. The demand for trauma
and surgical critical care workforce in the US has never been higher and a severe shortage of
surgeons in this field is looming. The need for academic trauma and critical care practitioners that
can not only treat patients, but have the necessary skills to conduct basic, translational, and clinical
research to advance our knowledge and develop new treatments is even greater. The fundamental
purpose of this training program is to provide surgical residents and pediatric critical care medicine
fellows with an intensive two-year research training experience that will prepare them for an academic
career in trauma and critical care. Our training program has evolved over the past 24 years into a
highly structured and collaborative program that involves participants from multiple clinical and basic
science disciplines. Our trainees benefit from a team-based mentorship philosophy, outstanding
institutional support, and a broad range of educational opportunities. The training program is
designed to teach surgical residents, pediatric critical care fellows, and conventional PhD
postdoctoral fellows to assess a trauma-related problem, identify the key questions, formulate
hypotheses, and then design and conduct the appropriate experiments to test the hypotheses and
answer the questions.

Public health relevance
Project Narrative The fundamental purpose of this training program is to provide surgical residents, pediatric critical care medicine fellows, and conventional PhD postdoctoral fellows with an intensive two-year research training experience that will prepare them for an academic career in trauma and critical care. The training program is designed to teach trainees how to assess a trauma-related problem, identify the key questions, formulate hypotheses, and then design and conduct the appropriate experiments to test the hypotheses and answer the questions.